Re-animation of the eye with neodymium actuation system

Partial ophthalmoplegia due to a single cranial nerve palsy are common with an estimated
700,000 cases in the US and 15,000 new cases annually in the VA, with the most common
causes being stroke and diabetes. There can also be bidirectional and total ophthalmoplegia due
to multiple cranial nerve palsies, for which there is currently no effective treatment. Unresolvable
diplopia is common in ophthalmoplegias, resulting in visual confusion, increased risk for falls, and
reduced quality of life on par with glaucoma and AMD. Ophthalmoplegias affect many aging
Veterans with neurological diseases and younger Veterans with severe polytrauma, making them
a priority for VA research.
We propose to reanimate the eye in ophthalmoplegias by attaching a NdFeB magnet to the
eye and actuating the ocular magnet with a larger magnet fixed externally, on an eyewear
temple between the ear and the eye. NdFeB are quite powerful and widely available, as they
are commonly used in cell phones and toys, and therefore the safety profile is well-established.
In unidirectional cases, such as 6th nerve palsy, a static magnetic force is sufficient and does not
require a power source. In bidirectional or total ophthalmoplegias, a small motor will rotate the
spectacle magnet to control the eye movements.
Prior studies have already made calculations suggesting NdFeB actuation of the eye is possible
at clinically feasible component sizes and separations, but the approach has never been
pursued beyond this step. This project will move the field forward by creating a realistic eye
model, design and optimizing a prototype system, and acquiring feasibility data for methods of
fixing the ocular magnet 1) surgically, and 2) non-invasively via a magnetic scleral contact lens.

Public health relevance
Ophthalmoplegia refers to paralysis of eye movement typically caused by stroke, head trauma, or diabetes, and can be uni-directional or bi-directional. Current treatments for severe ophthalmoplegia are extremely limited. This project aims to determine the feasibility of magnetic actuators as part of a prosthetic device for the rehabilitation of ophthalmoplegia.